CSULB Research Initiative for Scientific Enhancement 2020-2025

Program Director/Principal Investigator (Last, First, Middle): Buonora, Paul
CSULB Research Initiative for Scientific Enhancement 2020-2025
Project Summary
In spite of much effort, the level of participation by individuals historically underrepresented in the United States
biomedical, clinical, behavioral and social sciences research enterprise persists. Building upon the momentum
provided by the California State University, Long Beach’s historical and ongoing commitment to training, best
practices from our BUILD, MARC, and RISE programs, and the growing literature on the development of
scientists from underrepresented (UR) and underserved communities we propose to address both the
recruitment and training of future biomedical researchers through this proposed work.
The proposed program includes activities collectively designed to attract students from diverse underserved
communities and help support and strengthen their identity as scientists. The program provides a progressively
rigorous educational environment through skills development courses, learning community activities,
workshops and seminars, coupled with intensive research experiences that promote critical, analytical,
quantitative, creative thinking, and research skills that prepare participants to successfully compete in Ph.D.
programs in biomedical fields. The program will:
1. develop and pilot a new early engagement in research laboratory course for freshman and sophomore
students to get a taste of applied research projects of CSULB faculty members. The community focus
of the applied research is designed to attract those new to the idea of research careers.
2. support the expansion of interest in research careers at CSULB, we will also expand our existing
undergraduate RISE Fellows program from 20-30 trainees while maintaining our track record of
success in the admission to and completion of Ph.D. degrees in the biomedical sciences.
3. take advantage of the strength of M.S. degree research at CSULB, we will continue our trainee M.S.-to-
Ph.D. Fellows program, serving those students in need of additional training before entry into Ph.D.
programs and biomedical research careers.
The goals are 1) the early engagement course becomes part of the CSULB Research Curriculum and serves
to increase interest in biomedical research careers, 2) to demonstrate how to expand our undergraduate
Fellows program without sacrificing our outcomes, and 3) to further strengthen our development of M.S.
degree candidates into viable Ph.D. level researchers by assessing our training model.

Public health relevance
Project Narrative The proposed California State University Long Beach (CSULB) RISE Program is designed to strengthen the biomedical research scientist-producing pipeline – especially for those underrepresented in biomedical research. There are three components to the Program: one focused on recruiting a diverse pool of first- generation students to research through an early engagement research laboratory course, one focused on recruitment and training of undergraduate students through coursework and research laboratory experience leading to their entry into doctoral study and research careers, and the third focused on master’s students who will receive course and research laboratory training to prepare them to enter doctoral study and research careers in the biomedical and behavioral sciences.